Lactobacillus-vectored Alkaline Phosphatase to Mitigate Alcohol-induced Leaky Gut and LPS Endotoxin Load in the Gut

PROJECT SUMMARY/ ABSTRACT
Alcohol misuse is one of the leading causes of mortality, accounting for 178,000 deaths and over 249 billion in
medical costs and lost productivity annually in the United States. Chronic alcohol consumption induces gut
dysbiosis, increasing intestinal permeability and Gram-negative bacteria, subsequently raising
lipopolysaccharide (LPS, endotoxin) levels, and leading to endotoxemia, systemic inflammation, and organ
dysfunction. Alkaline phosphatase (AP) is an endogenous enzyme produced in the intestine and plays a key role
in detoxifying LPS. Oral administration of Intestinal AP (IAP) attenuated alcohol-induced hepatosteatosis in mice
and reduced LPS content in cecal contents and blood and prevented metabolic syndrome in mice. However, oral
administration of AP has a challenge of short half-life, poor bioavailability, protease susceptibility, degradation in
the acidic and enzyme-rich environment of the stomach, the need for frequent administration at higher
concentrations and lack of sustained supply in the intestine. BiomEdit has developed a proprietary Lactobacillus-
vectored Drug Delivery Technology (LactoDDT®), which has previously demonstrated its capacity to prevent
alcohol-induced leaky gut, partially reduce proinflammatory cytokines and efficiently deliver nanobodies and
other targets to gastrointestinal (GIT) tract. BiomEdit also has developed a proprietary AP (InPro®), which
neutralizes LPS from different bacteria, reduces LPS-induced cytokine expression in RAW 264.7 macrophages
and increases native intestinal AP and improves LPS induced intestinal morphology and restores microbial
homeostasis in weaned pigs. Here, we propose to apply a two-pronged approach using: 1) LactoDDT® chassis
to prevent alcohol-induced gut leakiness and 2) LactoDDT®-produced AP in the GIT to reduce alcohol-induced
increase in endotoxin levels in the gut and its systemic translocation. Our approach will be a paradigm shift in
AP delivery overcoming many of the limitations associated with oral administration of AP. SA1: Generation of
engineered live biotherapeutics (eLBPs) delivering functional InPro®. In this aim, we propose to generate a total
of 20 eLBPs delivering InPro® and evaluate these eLBPs to neutralize LPS in an in vitro assay. SA2: Evaluation
of eLBPs for efficacy in a binge-on-chronic alcohol model of leaky gut. In partnership with our collaborator at
LSU, we will evaluate the efficacy of final 2 eLBPs with the highest InPro® secretion and activity in a binge-on-
chronic alcohol model of leaky gut in mice. A successful outcome of this Phase I work is development of a live
bio-preventative or -therapeutic aimed at reducing alcohol-induced leaky gut and increase in LPS load in the gut
and its systemic translocation following recent or ongoing alcohol consumption. In Phase II, we will advance the
final candidates towards preclinical development in a binge-on-chronic alcohol model of leaky gut and prepare
a risk-benefit assessment package for pre-IND meeting with FDA.
1

Public health relevance
PROJECT NARRATIVE Alcohol misuse is one of the leading causes of mortality, accounting for 178,000 deaths and over 249 billion in medical costs and lost productivity annually in the United States. Chronic alcohol consumption induces gut dysbiosis, increasing intestinal permeability and Gram-negative bacteria, thereby elevating lipopolysaccharide (LPS, endotoxin) levels, and leading to endotoxemia, systemic inflammation, and organ dysfunction. Alkaline phosphatase (AP) is an endogenous enzyme that is produced in the intestine and plays a key role in detoxifying LPS, improving gut barrier function, and modulating the microbiome. Oral administration of Intestinal AP (IAP) attenuated alcohol-induced hepatosteatosis in mice and reduced LPS content in cecal contents and blood and prevented metabolic syndrome in mice, highlighting its immense potential as a therapeutic or a prophylactic for alcohol misuse. However, oral administration of AP is not a feasible and sustainable approach to prevent metabolic endotoxemia due to the facts that AP is prone to degradation by enzymatic action, low pH or other adverse conditions encountered during transit in the stomach. Here, we propose to apply a two-pronged approach using: 1) LactoDDT® chassis to prevent alcohol-induced gut leakiness and 2) LactoDDT®-produced AP in the GIT to reduce alcohol-induced increase in endotoxin levels in the gut and its systemic translocation following recent or ongoing alcohol consumption. 1